EFFECT OF AGE AND ENDURANCE TRAINING ON LIPID METABOLISM

To provide new information on the influence of age and endurance training on fat metabolism and sympathetic nervous system activity during submaximal exercise.